Cognitive heterogeneity in those with high Alzheimer's Disease Risk

PROJECT SUMMARY
The insidious nature of Alzheimer’s disease (AD) spans decades and adds complexity to detect the disease
earlier in its course. A significant consideration is that those identified as at risk for AD may not necessarily
develop clinically expressed disease. Traditional methods for detecting behavioral indices associated with
those with AD risk have relied mainly on cognitive changes characterized by neuropsychological (NP) test
performances. But heterogeneity exists both within and across cognitive performance measures, suggesting
that NP tests themselves are not sufficiently reliable in differentiating those at risk of progressing from
preclinical to clinical AD versus those who do not. Thus, the primary objective of this renewal application is to
develop a data-driven framework to better elucidate the cognitive heterogeneity associated with the earliest
stages of AD, particularly at the preclinical (pre-symptomatic) and prodromal (mild cognitive impairment; MCI)
stages. To meet this objective, we will profile the cognitive characteristics of persons with high risk AD (e.g., A+
and/or T+; amyloid / tau) from 1) plasma, 2) post-mortem tissue and 3) positron emission tomography (PET)
scans to determine what cognitive profiles differentiate those who will and will not progress (e.g., asymptomatic
[does not progress] versus pre-symptomatic [does progress]; MCI stable versus MCI progressors). Cognitive
characterization will utilize standardized scores from NP tests and novel digital cognitive metrics. We will also
evaluate whether the addition of neuroimaging measures as a biomarker of “N” (neurodegeneration) combined
with cognitive metrics will increase high AD risk group differentiation. We will further leverage the richness of
the Framingham Heart Study’s 7+ decades of demographic, clinical and other biomarker data to link cognitive
signatures of those with high-risk AD at their symptomatic origins. As an attempt to tie our findings with the
frameworks conducting population-level risk assessments, in an exploratory analysis, we will fuse information
collected at the pre-symptomatic/MCI stages and develop multimodal data analytic approaches to predict those
who are at high risk of developing the disease and compare our findings with traditional statistical methods.
The scientific importance of outcomes from our approach is the potential contribution to the growing body of
literature focused on precision identification of individuals who are at high disease risk and most likely to
progress to clinically expressed disease, and thus on whom intervention is most likely to be warranted and
effective.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) diagnosis is not inevitable in persons living with known risk factors such as old age, female sex, and cardiovascular disease. This renewal application attempts to go back in time and characterize the cognitive profiles of those who are at high risk of developing the disease. Rather than waiting for the disease to develop and managing the affected individuals, our proposed strategy has the potential to redefine early interventions in those with high AD risk.